Lipocalin-2, a mitokine that mediates white to brown fat crosstalk

Project Summary/Abstract
One third of American adults are suffering from obesity. Obesity significantly contributes
to the prevalence of numerous other life-threatening diseases, such as type 2 diabetes,
cardiovascular diseases, cancers, etc. Although substantial resources have been
invested to resolve this major public health threat, the fact is that, currently, only limited
methods of pharmacological therapeutics have been developed to treat obesity. An in-
depth understanding of the reasons for obesity is urgently needed to facilitate finding
more effective therapeutics. There are two types of fat tissue in humans: white and
brown adipose tissue. They have different morphologies and perform distinct functions.
While white fat stores excessive energy in the form of lipids, brown fat consumes
excessive energy through adaptive thermogenesis (i.e., generating heat). A common
phenomenon in human obesity is the conversion of brown fat into white fat, a process
identified as whitening. Reversing brown fat whitening activates brown fat function and
exerts anti-obesity effects. The overarching goal of this study is to investigate the role of
lipocalin 2 (LCN-2), a potential factor that promotes brown fat whitening. The applicant
recently performed a series of screenings in his adipocyte mitochondrial dysfunction
model. LCN-2 was suggested to be a leading factor that drives the white to brown
adipose tissue crosstalk to induce brown fat whitening. Therefore, this proposal is set out
to evaluate the central hypotheses: LCN-2, a secreting factor from the white fat, is
induced by mitochondrial distress and promotes brown fat whitening. In Aim 1, cell
culture systems (in vitro) will be utilized to demonstrate that LCN-2 is required in brown
fat whitening. In Aim 2, evidence from mice (in vivo) will be provided to further evaluate
the role of LCN-2 in brown fat whitening and metabolic consequences (i.e., cold
intolerance and obesity). This study will fill a knowledge gap through defining a novel
whitening factor in understanding how the brown adipose tissue becomes whitened.
Furthermore, this study has translational merits because either neutralization of LCN-2
per se or inhibition of the LCN-2 receptor holds an enormous potential to ameliorate
brown AT whitening and, in turn, to identify innovative therapeutics that alleviate obesity.

Public health relevance
Project Narrative Crosstalk factors the completion and between white and brown adipose t issues i s key to energy homeostasis, but the underlying crosstalk are poorly understood. This proposal ims to investigate the role of a mitokine, lipocalin-2, in controlling white to brown fat crosstalk, as well as i ts contribution to whitening of brown adipose tissue. Successful of proposed studies will enhance our understanding of the pathogenesis of brown fat dysfunction obesity and will facilitate discovering novel therapeutics against obesity and its associated comorbidities. a